CiLostAzol for pReventIon of recurrent sTroke in Africa (CLARITY-Africa)

PROJECT SUMMARY
Global estimates suggest that sub-Saharan Africa (SSA) now has the highest incidence, prevalence, and worst
survival outcomes of stroke. With an estimated 1.4 million stroke survivors, outcomes of stroke in SSA are
abysmal with 1-month case fatality at 30% and 3-year mortality rate of 84%. Stroke survivors in Africa are at an
inordinately high (and worsening) risk of adverse outcomes including recurrent stroke and cardiac events over
the medium- to long-term. Given the paucity of resources in the region, testing of therapies, which are potentially
highly clinically efficacious and cost-effective, while developing local stroke research capacity and contributing
to the global secondary stroke prevention evidence base, is urgently needed. Cilostazol, a phosphodiesterase 3
inhibitor, has shown promising efficacy and safety mainly among an Asian population by cutting risk of major
adverse cardiovascular events including stroke, in half, when added to aspirin or clopidogrel (8% vs. 4%, HR
0.52, 95% CI 0.35-0.77), with no increased risk in bleeding or serious adverse events. Cilostazol’s potentially
strong efficacy, presumed pleiotropic effects, and relatively low cost, make it a highly appealing agent for use in
stroke-prone, low-resource settings. Therefore, the overall objective of the CiLostAzol for pReventIon of recurrent
sTroke in Africa (CLARITY-AFRICA) study is to deploy a hybrid study design to demonstrate the efficacy and
safety of cilostazol twice daily in reducing MACE over 24 months vs. placebo among 800 recent stroke patients
encountered at 12 hospitals in Ghana. Secondly, CLARITY-AFRICA also seeks to develop an implementation
strategy for routine integration and policy adoption of cilostazol for post-stroke cardiovascular risk reduction in
an under-resourced system. Given its compelling efficacy among a predominantly Asian population, the National
Institute of Neurological Disorders and Stroke (NINDS) is poised to fund a US-based clinical trial to assess the
longer-term efficacy and safety of cilostazol in a study titled CiLostAzol for pReventIon of recurrent sTroke
(CLARITY). We are also aware that European and Australian funding agencies are considering stroke trials of
cilostazol. A concurrently executed CLARITY-Africa trial would allow recruitment of a historically under-
represented and high-risk group (Africans), test a therapy that if efficacious could be affordable for broader
regional implementation, permit transcontinental mentorship/collaborations, and leverage NINDS impending
investment. CLARITY-AFRICA will assess implementation outcomes such as adoption, acceptability, cost,
pertinent to uptake of cilostazol in Ghana to inform policy. Regardless of its outcome, findings from CLARITY-
AFRICA will contribute meaningful information from the African perspective to inform the formulation of
guidelines for global adoption of cilostazol into routine care for secondary CVD risk prevention by international
bodies such as the World Health Organization.

Public health relevance
NARRATIVE Our objective for this research is to determine the efficacy and safety of cilostazol (a novel blood thinner) added to standard therapy compared with standard of care therapies in reducing recurrent strokes, heart attacks and cardiac deaths among recent Ghanaian ischemic stroke or transient ischemic attack survivors over 24 months. Participants in this trial will be enrolled from 12 hospitals including primary, district/regional, and tertiary levels across 6 regions (states) in Ghana to broadly capture patient and clinician experiences with the cilostazol and enhance the generalization of study findings. We also seek to develop an implementation strategy using a consultative, multi-stake holder engagement for routine integration and policy adoption of cilostazol as a safe, cost-effective, approach for post-stroke cardiovascular risk reduction in a resource-limited setting while building clinical trial research capacity in Africa.